Research Program Award (R35 Clinical Trial Optional) - Dr. Robyn Klein NINDS

PROJECT SUMMARY/ABSTRACT
Viral infections are now recognized as risk factors for diseases of progressive pathological forgetting,
supporting a new paradigm in neuroimmunology whereby innate immune molecules that function as
modulators of a variety of normal CNS functions induce neurodegenerative diseases during host-pathogen
responses. Studying virus-mediated cognitive dysfunction through the multidisciplinary prism of immunology,
neuroscience, and virology is critical for the identification of novel mechanisms of disease, discovery of
neuroimaging tools and therapeutic treatments for a wide range of diseases of memory disorder. In my
laboratory we made unanticipated, paradigm-shifting discoveries of the roles of CNS infiltrating mononuclear
cells in microglial-mediated synapse elimination, disrupted adult neurogenesis, and generation of neurotoxic
astrocytes using novel models of recovery from encephalitogenic flaviviruses, West Nile (WNV) and Zika
(ZIKV) viruses. We identified classical complement proteins and cytokine receptor signaling as novel molecular
mediators that regulate synapse elimination, neural stem cell (NSC) fates, neuron-microglia and microglia-
astrocyte crosstalk within cortical structures that regulate memory formation and maintenance. We have also
begun leveraging novel neuroimaging modalities to develop biomarkers that may be used to predict and
monitor patients at risk for memory disorders. Our aim is to understand the mechanisms that induce alterations
in synaptic connections and methods of repair that contribute to disruption of neuronal networks after recovery
from viral infections. Our research program focuses on three broad areas related to the roles and regulation of
innate immune molecules involved in spatial learning using novel murine models of post-infectious cognitive
dysfunction. First, using genetic, pharmacologic and PET-MRI, we will identify and define molecular
interactions between T cells and microglia or neurons that drive the generation and maintenance of resident
memory T cells that promote cognitive dysfunction. We will use scRNAseq under BSL3 conditions to screen for
genes and pathways to be targeted via cell-specific deletion of cytokine or chemokine receptors, or
administration of agents that inhibit or enhance pathways. We will also develop diagnostic tools that employ
ABSL3 PET-MRI. Second, we will define how microglia-astrocyte-NSC interactions in the context of recovery
from CNS viral infections limit repair and recovery. We will use global and conditional gene targeting in mice to
delineate the in vivo roles of cytokines in neural cell types that regulate astrocyte inflammasome activation and
its relationship to neuronal and synapse recovery. We will also define innate immune mechanisms that direct
and maintain astrogenosis during acute viral infection and recovery using PET-MRI detection of P2X7R, a
marker of reactive astrocytes. Finally, will utilize reporter mice/fate mapping, bone marrow chimeras and
scRNAseq to delineate the cytokine-mediated roles of myeloid cells in the generation of neurotoxic astrocytes
during WNND recovery. Third, we will examine innate immune mechanisms triggered after viral infections that
negatively impact cortical connectivity and determine whether neuroimaging can be used to predict and follow
this process. Specifically, we will combine genetic approaches with functional optical intrinsic signal imaging of
hemoglobin and calcium dynamics to define mechanisms that negatively impact cortical connectivity. Our
research program will define new concepts in the molecular neuroimmunological regulation of synapses, T cell
and glial interactions, inform studies of related processes throughout the nervous systems, and will likely
enhance our understanding of neurodegenerative and other disorders of memory.

Public health relevance
NARRATIVE Neurotropic RNA viruses continue to emerge at an increasing rate, causing severe acute neuroinvasive syndromes with majority of survivors exhibiting significant neurocognitive deficits that persist for years after clearance of virus. Most of these are vector-borne infections, however, the most recently emerged RNA viruses, Zika virus and severe acute respiratory syndrome coronavirus (SARS-CoV)-2, can be transmitted person-to-person. In addition, evidence that viruses trigger the development of neurodegenerative diseases, such as Alzheimer's disease and other dementias, is mounting. There are limited studies of the mechanisms of post-infectious, progressive pathological forgetting, which are poorly understood. There are also currently no diagnostic or treatment modalities for cognitive sequelae in patients that recover from viral infections of the central nervous system,.